Determinants of Clostridioides difficile colony dimorphism

SUMMARY ABSTRACT
Clostridioides difficile is among the most common causes of nosocomial infections with disease ranging from
antibiotic-associated diarrhea to pseudomembranous colitis. Secreted toxins are largely responsible for
disease development, yet many aspects of C. difficile physiology and virulence remain poorly understood.
Recent work has revealed that C. difficile produces two colony morphotypes—a rough colony variant and a
smooth colony variant—and can reversibly switch them. This phenomenon is conserved among diverse C.
difficile strains. The two morphological variants differ in several ways. Bacteria from rough colonies are longer
and often found in chains, exhibit greater surface motility and diminished swimming motility, produce less
biofilm biomass, and show greater pathogenicity in animal models compared to the smooth colony counterpart.
Our prior work linked colony morphology and the correlated phenotypes to the expression of genes encoding a
signal transduction system, CmrRST, but the molecular mechanisms by which C. difficile develops rough and
smooth colony morphologies have yet to be defined. The objective of this study is to identify genes required
for formation of each colony morphotype and to determine the roles of these genes in cell morphology, motility,
biofilm formation, and virulence. In Aim 1, we propose three complementary yet independent mutagenesis and
screening strategies to identify genes required for rough and smooth colony development. This work takes
advantage of mutants designed to yield only one colony morphotype. The in vitro phenotypes of the mutants
obtained through the genetic screens will be evaluated to determine the broader impact of the identified genes
on C. difficile physiology and virulence traits. In Aim 2, we will examine how one identified mutation results in
strictly rough colonies and assess its ability to colonize and cause disease in a mouse model of C. difficile
infection. Similar strategies will be used to characterize additional mutants obtained in Aim 1. Pilot studies with
the proposed approaches have identified multiple candidate genes predicted to affect cell division. As such,
these gene products may serve as new targets for therapeutic development, yet almost none of these genes
have been previously studied. The proposed research will identify factors contributing to disease relevant
phenotypes including cell division proteins, facilitating efforts to combat C. difficile infection.

Public health relevance
PROJECT NARRATIVE Clostridioides difficile is a major public health concern that can cause intestinal diseases including diarrhea and pseudomembranous colitis. C. difficile develops two colony morphologies that exhibit differences in multiple virulence-associated phenotypes. The objective of the proposed study is to identify and characterize genes necessary for colony dimorphism, which may reveal new targets for development of therapeutics for C. difficile infections.